Enzyme-encapsulated protein frameworks for optimized cascade biocatalysis

Project Summary
While incorporating multiple enzymes into a solid matrix holds significant potential for enhancing catalytic
efficiency in complex cascade reactions, progress in this direction is hampered by two critical challenges: (1) a
lack of understanding of how structural factors such as substrate accessibility and spatial arrangement of multi-
enzyme assemblies affect overall catalytic efficiency, and (2) enzyme instability, which limits the long-term
reuse of biocatalysts. To address these challenges, we will develop protein framework materials self-
assembled from enzyme-encapsulated virus-like particles (VLPs) and evaluate their catalytic activities while
systematically modulating the structural factors of these frameworks. The scientific objective of this research is
to identify the extent to which structural factors, such as substrate accessibility and enzyme spatial
arrangement in the frameworks, affect overall catalytic efficiency. We hypothesize that the catalytic efficiency of
multi-enzyme protein frameworks can be significantly improved through the rational design of these structural
factors. As a model cascade reaction, we will use a pathway from glucose to pyruvate because cell-free multi-
enzyme pathway for this cascade reaction has been well established.
We will test the hypothesis through three aims: (1) encapsulate three key enzymes involved in the pathway
within VLPs and evaluate their catalytic activities and stabilities in comparison with free enzymes, (2)
investigate how the structure (random or ordered) and interstitial spacing of single-enzyme frameworks affect
catalytic efficiency, and (3) investigate how spatial arrangement of multiple populations of enzymes within the
frameworks affect catalytic efficiency. Through these aims, we will identify key structural factors which affect
overall catalytic efficiency of multi-enzyme assemblies. Since the assembly of VLPs into the framework
structure is independent of the enzymes encapsulated within the VLPs, the findings from this research will
have broad applicability for a wide range of cascade reactions, enabling more efficient synthesis of biologically
active and pharmaceutical molecules. Furthermore, this project will provide valuable hands-on research
training for students at California State University, Fresno (CSU-Fresno), many of whom are from historically
underrepresented communities in higher education. Collectively, this project will strengthen both the research
capabilities and educational efforts at CSU-Fresno.

Public health relevance
Project Narrative While incorporating multiple enzymes into a solid-state matrix to catalyze cascade reactions holds significant potential for the efficient synthesis of drug molecules, progress in this direction is limited due to the lack of generalizable design principle. This research aims to identify key structural factors for designing solid-state multi-enzyme assemblies with optimized catalytic efficiency. The proposed research is highly relevant to the NIH's mission and public health because the design principle of multi-enzyme assemblies identified through this research could be applied to the synthesis of a wide range of pharmaceutical molecules, ultimately contributing to more efficient drug manufacturing.